Gradient biomaterials to investigate niche regulation of hematopoiesis

ABSTRACT
The hematopoietic system offers an ideal biological system to develop tools to study how dynamic matrix,
metabolic, and cellular selection pressures influence stem cell fate. Hematopoiesis is the process where the
body’s blood and immune cells are generated from a small number of hematopoietic stem cells (HSCs). HSC
quiescence, self-renewal, and differentiation take place in, and are regulated by, unique regions of the bone
marrow termed niches. HSCs are also the functional unit of therapeutic bone marrow transplants following
myeloablative therapies. A major goal of the hematology community is to selectively expand HSCs without
sacrificing a subpopulation of quiescent, long-term repopulating HSCs required for life-long hematopoiesis. Yet
while the marrow is known to change substantially across the lifespan, studies of the influence of niche
remodeling on HSC behavior are in their infancy. The long-term goal of this Stimulating Hematology Investigation
New Endeavors (SHINE) project is to advance tissue engineering platforms to achieve HSC expansion without
exhaustion. In the previous funding period (R01DK099528) we established a tissue engineering ecosystem to
examine the coordinated impact of niche-inspired biophysical signals on HSC fate. We developed microfluidic
tools for extended culture of primary murine HSC in miniaturized gelatin hydrogels containing marrow-inspired
gradients of stiffness, niche cells, and soluble vs. immobilized biomolecules We showed the kinetics of HSC-
niche cell crosstalk can be manipulated via biomaterial design to enhance retention of quiescent HSCs.
Mesenchymal stem cells (MSCs) within the marrow are increasingly believed to dynamically remodel the niche
and provide powerful signals to influence HSC fate. Hence, the objective of our renewal is to use an innovative
granular biomaterial to investigate the coordinated action of MSC remodeling and hypoxic stress on functional
changes in HSC activity. We hypothesize the mosaic nature of the bone marrow can be replicated as jammed
assemblies of cell-laden hydrogel microdroplets. We will create granular hydrogels from MSC and HSC
microdroplets to trace the consequences of matrix remodeling, metabolic constraint, and MSC-HSC crosstalk on
HSC fate. To accomplish this goal we will first establish an engineered model of MSC-mediated niche remodeling
(Aim 1). We will define shifts in HSC-MSC crosstalk under hypoxia (Aim 2). And we will evaluate a mosaic
granular hydrogel model of the multicellular marrow (Aim 3). Granular hydrogels provide the technical basis for
creating mosaic niche analogs necessary to study remodeling mediated effects on HSC activity. The well-
characterized murine hematopoietic system provides a rigorous framework to evaluate ex vivo regulatory
processes in niches whose rarity and complexity limit direct in vivo study. Consistent with score-driving criteria
of the SHINE program, we will develop essential tools to rigorously assess how dynamic processes of matrix
remodeling and HSC-niche cell crosstalk inform HSC stemness that is directly relevant to the NIDDK mission.

Public health relevance
NARRATIVE The body’s full complement of blood and immune cells are generated from a small number of hematopoietic stem cells (HSCs) in regions of the bone marrow termed niches. Niches provide matrix, metabolic, and cell-cell communication signals that influence HSC activity and which evolve over time in response to ageing and disease. The proposed research will develop a tissue engineering model of niche remodeling to selectively expand HSCs ex vivo for therapeutic and experimental applications.